Refining neurophysiological biomarkers of epilepsy using deep learning to guide pediatric epilepsy surgery

PROJECT SUMMARY/ABSTRACT
Dr. Hiroki Nariai is a pediatric epileptologist/clinical neurophysiologist whose long-term goal is to be a leading
physician-scientist in pediatric epilepsy, using key biomarkers to effectively treat children with epilepsy and
reduce their mortality and morbidity. In this project, Dr. Nariai proposes to study medication-resistant focal
epilepsy in children by integrating computational electroencephalogram (EEG) analysis, deep learning, and
advanced statistics to investigate and validate high-frequency oscillations (HFOs)—a promising spatial
biomarker of the epileptic brain. More than one-third of children with epilepsy are resistant to medications and
are therefore potential candidates for epilepsy surgery. To achieve postoperative seizure freedom, one must
remove or disrupt the epileptogenic zone (EZ), defined as the brain area that is indispensable for generating
seizures, while preserving the eloquent cortex (EC), defined as the brain area that controls essential functions.
Thus, identifying biomarkers that accurately localize and discriminate EZ from EC will be groundbreaking. HFOs
are recorded via intracranial EEG as short bursts of high-frequency neuronal activity and are often observed in
EZ. However, the major challenge is that physiological HFOs generated by healthy brain tissue complicate the
clinical interpretation of HFOs. Therefore, there is a critical need to distinguish between pathological and
physiological HFOs. Dr. Nariai hypothesizes that deep learning-based algorithms can distinguish pathological
and physiological HFOs based on subtle morphological features linked to specific biological mechanisms.
Through this K23 career development award, Dr. Nariai proposes to accomplish the following training goals: (1)
acquire skills in an advanced computational EEG analysis to enable customized quantification of HFOs in a large
dataset, (2) gain knowledge of the theory of deep learning and skills in its application in EEG signal processing
to enable morphological assessment of HFOs, and (3) develop proficiency in advanced statistics in clinical
research to validate prediction models and gain knowledge in clinical trials. Under the joint mentorship of leading
researchers led by Dr. Jerome Engel, Jr., at UCLA, Dr. Nariai will build deep learning-based models in a large
retrospective cohort to define HFOs expressed in EZ (eHFOs) to represent pathological HFOs. In addition, HFOs
expressed in EC (ecHFOs) will be defined to represent physiological HFOs. The trained classifier will be analyzed
to obtain the computational definition of eHFOs and ecHFOs. Along with demonstrating that real-time HFO
analysis is feasible in a prospective cohort, eHFOs and ecHFOs will be analyzed to prove that HFOs can localize
and discriminate EZ from EC. Dr. Nariai has shown preliminary results supporting the feasibility of his proposed
approach. Completing the proposed goals will provide significant progress toward utilizing HFOs as a clinically
useful spatial biomarker of the epileptic brain to guide epilepsy surgery, which Dr. Nariai plans to pursue as an
R01 project.

Public health relevance
PROJECT NARRATIVE More than one-third of children with epilepsy do not respond to medications and are therefore candidates for epilepsy surgery. Developing a robust tool to identify abnormal brain areas for surgical intervention would be a groundbreaking advancement in treating children with epilepsy. This project aims to investigate promising spatial neurophysiological biomarkers of the epileptic brain known as high-frequency oscillations through a novel deep learning-based approach.